The Texas Resource Center on Minority Aging Research (RCMAR)

The Research Education Component (REC) will contribute to expand and strengthen the next generation of
leaders on minority aging and health disparities research, by supporting structured multidisciplinary research,
education and mentoring, individualized learning experiences, nationwide networking, and participation in
targeted multidisciplinary team science. For this renewal of the Texas RCMAR, the REC will perform activities
through a new partnership between the University of Texas Medical Branch (UTMB) and the University of Texas
San Antonio (UTSA), as well as continue our existing collaboration with UT-Austin. We will leverage
complementary resources from our three institutions to advance the overall theme of the Texas RCMAR. Over
the past cycle, the Texas RCMAR participating faculty have created a network of P30, R13, K12, KL2, T32,
individual K-awards, and other federal funding to support the program activities. To this network, we will
incorporate UTSA expertise in social/behavioral science. Our structured plan for mentoring and training scientists
recruited at the assistant professor level, takes advantage of existing strengths, integrates our best practices,
and launches new initiatives to recruit and retain scientists. Working closely with the Leadership & Administrative
Core (LAC) and the Analysis Core (AnC), the REC will seek to complete the following Specific Aims: Aim 1:
Identify, recruit, and retain qualified candidates who have the potential to develop successful careers in
minority aging and health disparities consistent with the mission and theme of the Texas RCMAR. We will do
this by implementing a clearly defined recruitment program that attracts promising Scientists to address the
RCMAR’s theme and aims, including a new initiative of ‘pipeline scientists’ that are engaged a year ahead of
their start in the program. We anticipate a new cohort of four new Scientists each year. Aim 2: Create and monitor
an Individualized Career Development Plan for each Scientist. Upon recruitment, a 2-year Plan as RCMAR
Scientist will identify a lead mentor and mentoring team members with defined roles, regular meetings, and
specific professional development experiences. The Plan will include benchmarks, timeline, and outcomes. Aim
3: Implement and monitor a Structured Program of Mentoring and Research Education, with activities for
the scientists in the program. The Pilot Project in year-1 of their Plan will serve as the platform for the structured
program to boost the scientists’ career in minority aging, followed by a focus in year-2 on productive team science
and seeking external funding. Activities will include biweekly group meetings, training in social and behavioral
aspects of minority aging and health disparities, team science, the preparation and submission of grant
proposals, a K-award discussion group, and training in the responsible conduct of research. RCMAR Scientists
will maintain a Scientific Portfolio that documents milestones and reflects progress, which will be used in a formal
process to evaluate achievements and improve the effectiveness of the program. RCMAR Scientists will be
mentored by experienced senior faculty and a multidisciplinary team of affiliated faculty from our institutions.